Probing human HSC genesis in a flow-directed 3D hemogenic vascular niche model

Title: Probing human HSC genesis in a flow-directed 3D hemogenic vascular niche model
Project Summary/Abstract:
Human induced pluripotent stem cells (PSCs) represent a promising and essentially limitless source of
hematopoietic stem, progenitor, and terminally differentiated blood cells for a variety of “off-the-shelf” cellular
therapies and disease modelling applications. However, a major obstacle to translating this promise to the clinic
is that current protocols for differentiating blood cells from PSCs have not clearly defined the microenvironmental
niche signals necessary to support the emergence of functionally transplantable and durably self-renewing
hematopoietic stem cells (HSCs). We hypothesize that distinct biochemical signals and fluid mechanical forces
specific to the aortic vascular niche, where HSCs first emerge, synergize to promote HSC fate from hemogenic
endothelial cell (HEC) precursors. Our preliminary studies suggest a potential novel role for signals transduced
downstream of hydrostatic pressure in establishing self-renewal programs essential to HSC fate. We have
recently developed a 3D engineered hemogenic vascular niche which supports the induction of hematopoietic
fates from PSC-derived endothelium. The primary objective of this proposal is to leverage this innovative platform
to test how intrinsic arterial maturation, biomechanical forces, and mesoderm-derived growth factors synergize
to promote HSC genesis ex vivo. We propose that replicating the temporal and spatial integration of synergistic
biochemical and biomechanical factors will be critical to elucidating the mechanisms by which HSCs can
efficiently and reproducibly be derived from PSCs. To accomplish the goals of this proposal, we will leverage the
complementary expertise of MPIs Dr. Hadland and Dr. Zheng along with the state-of-the-art techniques available
in their laboratories. We expect that success in these goals will accelerate the clinical translation of PSC
technologies to advance cellular therapies and disease modelling applications for various blood and immune
disorders.

Public health relevance
Project Narrative Hematopoietic (blood-forming) stem cells are used in transplantation to cure various diseases of the blood and immune systems, but the availability of these cells is limited by the lack of suitable donors for all patients who could benefit from this life-saving therapy. In this project, we propose to overcome this barrier by engineering a three-dimensional model recapitulating the embryonic vascular niche that supports the de novo generation of hematopoietic stem cells from pluripotent stem cells. This approach aims to provide an essentially limitless source of these cells for critical clinical and research applications.